Neural and Behavioral Indices of Balance Performance in Individuals with sensory loss

ABSTRACT
People with unilateral vestibular hypofunction (VH, peripheral disease of the inner ear) are
thought to develop visual dependence. They get dizzy and off balance in complex visual
environments. They sway more with dynamic visuals compared to static or with eyes closed
compared to open. Individuals with UHL are not regularly assessed for balance function, but those
with at least moderate hearing loss show increased risk for falls. Data from mechanistic studies
in our lab have demonstrated that individuals with UHL do not increase postural sway in the
presence of complex visual scenes as much as healthy controls, suggesting they are not as reliant
on visual input to maintain their balance. Based on these findings, we hypothesize that individuals
with UHL may reallocate attentional resources to motor control of balance (conscious movement
processing) to compensate for the loss of auditory cues. To test the hypotheses of visual
dependence in VH and conscious movement processing in UHL, this proposal will combine
behavioral assessments of balance with analyses of network-based functional connectivity from
resting-state functional magnetic resonance imaging (fMRI). The long-term goal of this research
is to identify the neurobiological index explaining balance behavior and develop an intervention
approach targeting functional connectivity differences that maximizes functional mobility gains in
people with sensory loss. In the current project we will address the following Specific Aims: Aim
1: Identify balance profiles for people with VH and UHL. Individuals with VH, UHL and controls
(N=24 each) will perform a battery of balance measures including static, dynamic, gait, and tests
targeting sensory and cognitive aspects of balance. We will also analyze their postural sway from
force plate data as they are tested in a virtual reality environment. Aim 2: Identify internetwork
functional connectivity differences in VH, UHL, and healthy controls. Resting-state fMRI data will
be acquired from VH and UHL (N=12 each) and compared to a distribution of healthy control data.
Aim 3: Determine the extent to which balance performance (Aim 1) correlate with neurobiological
data (Aim 2) in VH and UHL. We will calculate correlations between postural sway data and ratio
of attention-motor connectivity to attention-vision connectivity.
If we accomplish our aims, we will identify which balance domains are most affected by
vestibular and hearing loss and whether people with UHL should be regularly screened for
balance performance. We will establish which brain connections are altered by sensory loss and
the implications for balance. This knowledge will have important implications to public health for
improved assessment of balance and development of future interventions in VH and UHL.

Public health relevance
The proposed research is relevant to public health because vestibular disorders and hearing loss can triple one’s fall risk and have a profound effect on one’s independence and participation in activities of daily living. This project is relevant to the mission of the NIDCD because it is uncovering new knowledge to better the overall health of these individuals. By understanding the relationship between neurobiological differences and balance performance, we can be better positioned to improve balance and function in over 1/3 of adults in the United States who seek medical attention for vestibular disorders or hearing loss.